INSULIN SECRETION AND SENSITIVITY IN GESTATIONAL DIABETES MELLITUS

This study will investigate insulin secretion and sensitivity in women with gestational diabetes mellitus as compared to pregnant women with normal glucose tolerance and reassess at 6 weeks post partum. Nonpregnant, nondiabetic women will serve as controls.